Mechanisms Underlying Role of Intestinal P-glycoprotein in Inflammatory Bowel Disease

Project Summary/Abstract
Background and Innovation: P-glycoprotein (Pgp/MDR1), encoded by the ABCB1 gene protects intestinal
epithelium by mediating the efflux of xenobiotics and bacterial toxins from the mucosa into the lumen.
Polymorphisms in the human MDR1 gene have been associated with ulcerative colitis (UC) and Crohn's disease.
A decrease in function and expression of Pgp has been shown in mouse models of inflammation and patients
with Inflammatory Bowel Disease (IBD). Additionally, Pgp deficient mice spontaneously develop severe colitis
resembling human UC. However, the mechanisms underlying Pgp dysfunction in intestinal inflammation and IBD
pathogenesis remain elusive. Our exciting preliminary data provide strong evidence that Pgp deficiency induces
abnormal Paneth cell function (PC) with a significant decrease in lysozyme 1 and other PC-secreted antimicrobial
peptides (AMPs). PC dysfunction in Pgp knockout (KO) mice was associated with gut microbial dysbiosis
exhibiting an expansion of species linked to gut inflammation such as Turicibacter sanguinis, Alistipes sp., and
a decline in Bacteroides thetaiotamicron and short chain fatty acid (SCFA)-producing bacteria critical in limiting
the colonization of enteric pathogens. Indeed, previous studies have shown that Pgp KO mice are more
susceptible and vulnerable to enteric pathogen infection. Since Paneth cell AMPs play an essential role in host
defense against enteric pathogens and influence gut microbiome composition, our novel findings in Pgp KO mice
suggest that Paneth cell antimicrobial defect leads to gut dysbiosis that precedes inflammation in Pgp KO mice
and is likely to contribute to increased susceptibility to infection and or inflammation. Based upon these findings,
we hypothesize that “Pgp deficiency results in impaired Paneth cell function which triggers microbial
dysbiosis resulting in i) increased susceptibility to infection by enteric pathogens; ii) compromised
colonic barrier integrity contributing to the development of spontaneous colitis in Pgp KO mice”. We
further hypothesize that “restoration of AMP levels in Pgp KO mice maintains a healthy microbiome that
can prevent susceptibility to infection and development of spontaneous colitis”. To test this hypothesis,
Specific Aim 1 will investigate mechanisms underlying Pgp deficiency-induced Paneth cell defects in triggering
gut dysbiosis, increased susceptibility to infection by enteric pathogen (Citrobacter rodentium), compromised
epithelial barrier function and development of spontaneous inflammation in Pgp KO mice. We will also examine
the role of oral supplementation of AMP in preventing infection and inflammation in Pgp KO mice. Specific Aim
2 will examine mechanisms underlying Pgp deficiency-associated gut dysbiosis in compromised epithelial barrier
function and susceptibility to colitis by determining the impact of microbiota transfer from Pgp KO mice to
recipient germ-free (GF) mice with or without DSS-induced and IL-10 receptor antibody-induced colitis as well as
examining the effects of colonization of both Turicibacter sanguinis and Alistipes sp., together in eliciting similar
effects of Pgp deficiency on epithelial barrier function and inflammation in GF mice. Significance and Impact
to Veterans Healthcare: Despite advances in current therapies, many VA patients with IBD fail to respond to
treatment or lose their initial response over time and lack of treatment outcomes can further impart a substantial
financial burden on VA patients. Also, extended use of corticosteroids by elderly VA patients can lead to adverse
health conditions. Therefore, a better understanding of the molecular events contributing to the
pathophysiology of IBD is warranted. Our proposal investigates the novel role of Pgp deficiency-induced
abnormal Paneth cell function in gut microbial dysbiosis contributing to IBD. These studies are relevant to the
VA mission and are among the key VHA/ORD research priorities. Path to translation/implementation: The
proposed studies at the preclinical stage are crucial for identifying and developing novel and effective therapeutic
interventions for IBD that is prevalent among Veterans.

Public health relevance
Project Narrative P-glycoprotein (Pgp/MDR1), an efflux transporter plays an important role in maintaining intestinal homeostasis by actively extruding bacterial toxins and xenobiotics from the mucosa into the gut lumen. Pgp limits bacterial invasion and dissemination and its downregulation have been implicated in the pathophysiology of gut inflammation associated with IBD. However, the mechanisms underlying the role of Pgp deficiency in triggering gut inflammation are not well understood. The proposed studies are designed to unravel novel role of Pgp deficiency-induced abnormal Paneth cell function in triggering gut microbial dysbiosis resulting in compromised epithelial barrier function and inflammation in Pgp KO mouse model of IBD. The findings from these studies could be exploited for developing effective therapeutic interventions with specific focus on restoring the altered gut microbiome and healing mucosal inflammation.